Lens injury-mediated mechanisms of nervous system protection and axon regeneration

ABSTRACT
The most debilitating forms of nervous system injury are those affecting the central nervous system (CNS).
Neuronal circuits damaged by CNS injury exhibit very limited regeneration capacity, leading to enduring
neurological deficits. Retinal ganglion cells (RGCs), the projection neurons of the retina, transmit visual
information via the optic nerve tracts to the brain. In rodent models, optic nerve crush (ONC) induces RGC death,
and surviving RGCs fail to extend axons beyond the site of injury. An established method to promote RGC repair
following ONC is lens injury (LI). Recent research has revealed that a conditioning lens injury (cLI), applied
several days before ONC, results in significantly enhanced RGC protection and regeneration compared to LI
applied concurrently with ONC. However, the cellular and molecular basis underlying cLI-induced RGC repair
remains elusive and requires further investigation. In my preliminary studies, I employed single-cell RNA-
sequencing (scRNA-seq) on ocular tissues (retina, lens, and vitreous) under regenerative (cLI) and non-
regenerative (sham-operated) conditions, which led to the identification of a-Crystallins (encoded by Cryaa and
Cryab) as top candidates that are remarkedly upregulated in lens fibroblasts, lens epithelial cells, astrocytes,
and Müller glia. Immunofluorescence labeling of the retina demonstrated that a-Crystallins are enriched in the
optic nerve fiber layer following cLI. Furthermore, the application of recombinant a-Crystallins to primary RGCs
stimulated axon outgrowth in vitro. Importantly, we found post-translational modifications on a-Crystallins that
significantly enhance neurite outgrowth of RGCs. In Aim 1, I will conduct a-Crystallin loss-of-function studies
(Cryaa-/- and Cryab-/- mice) and gain-of-function studies with recombinant and AAV2-transduced wild type and
constitutively active a-Crystallins to test the hypothesis that a-Crystallins are necessary and sufficient for cLI-
induced RGC protection and axon regeneration. In Aim 2, I will focus on RGC intrinsic mechanisms of cLI-
induced axon regeneration. To this end, I have established methods for isolating RGC nuclei from mice subjected
to cLI and sham operation. These RGC nuclei will be used for multi-omics analyses (snRNA-seq and snATAC-
seq) to assess changes in chromatin accessibility and to identify core cLI-induced gene regulatory networks
(GRNs) associated with RGC protection and axon regeneration. By utilizing in silico approaches, I will identify
candidate signaling pathways and GRNS that promote axon outgrowth of injured RGCs. As an intermediary step,
I will evaluate the growth potential of candidate genes and signaling pathways in primary RGC cultures. The
most promising candidates from these in vitro investigations will then undergo testing for their ability to promote
RGC regeneration in vivo. The proposed studies aim to elucidate both extrinsic and intrinsic mechanisms
underlying the pro-regenerative effects of cLI on RGCs. The identification of such signaling pathways may have
broad implications for CNS neuron protection and axon regeneration.

Public health relevance
PROJECT NARRATIVE Lens injury promotes robust and extensive retinal ganglion cell (RGC) survival and axon regeneration following injury, providing a unique and biologically relevant neuro-repair mechanism in the central nervous system. The proposed project will identify lens injury-elicited molecular mechanisms for neuro-repair towards RGCs. The results of this project will provide new knowledge on core neurorepair gene programs that may be targeted for the treatment of central nervous system injury and disease.